Improving Health Outcomes Through Systems and Policy changes in Maine

Abstract
Current data models vastly underrepresent and often misrepresent, Wabanaki and Indigenous people.
The information and data provided by these models are considered a premier source for detailed
population information about our nation yet provide little to no detailed information on Wabanaki
communities. Wabanaki people also suffer from food insecurity and lack access to traditional foods. This
initiative will provide reliable and accurate information to drive the creation of a traditional, culturally
meaningful food system and inform State partners on needed policy changes to improve the access to
traditional foods while simultaneously providing information to Wabanaki communities and leaders on
housing, economic stability, and needed recovery efforts.